RFA-DP-21-001 Montana Pregnancy Risk Assessment Monitoring System (MT PRAMS)

Application for Funding Opportunity RFA-DP-21-001
Montana Pregnancy Risk Assessment Monitoring System (MT PRAMS)
Component A: Core Surveillance
PROJECT SUMMARY/ABSTRACT
The overall goal of the Montana Pregnancy Risk Assessment Monitoring System (MT PRAMS)
is to reduce maternal and infant mortality by collecting information that can be used to inform
maternal and infant health programs, health policies and maternal behaviors.
MT PRAMS collects Montana-specific information on the experiences of mothers prior to,
during, and after pregnancy. MT PRAMS provides important information used by public health
programs and professionals to improve the health of mothers and infants in Montana. Data will
be used to identify populations at risk, risk factors, and inform maternal and child health
programs by monitoring health behaviors and access to care.
MT PRAMS follows a nationally developed method for collecting information from a portion of
the women who give birth in Montana each year. A certain number of mothers are randomly
selected to participate in the survey each month. A paper survey is mailed to each of them. If
they don’t respond to three survey mailings and a follow-up letter, a telephone call will be used
to follow-up.
MT PRAMS covers key topics of information to maternal and child health, such as prenatal care,
oral health, medical risk factors, breastfeeding, tobacco use, and many others. MT PRAMS
provides data not available from other sources in Montana. Comprehensive analyses will be
performed of the data, and analytic results will be disseminated to program partners and
stakeholders.

Public health relevance
Application for Funding Opportunity RFA-DP-21-001 Montana Pregnancy Risk Assessment Monitoring System (MT PRAMS) Component A: Core Surveillance PROJECT NARRATIVE The Montana Pregnancy Risk Assessment Monitoring System (MT PRAMS) collects Montana- specific data on selected maternal behaviors and experiences that occur prior to, during, and shortly after pregnancy. MT PRAMS survey methods provide necessary data for Montana to monitor emerging issues that may arise during the data collection cycle including the response to post-disaster or pandemic surveillance needs.